Stigma, Romantic Relationships, and Alcohol Use Among Transgender and Nonbinary Young Adults

PROJECT SUMMARY/ABSTRACT
For transgender and nonbinary (TNB) people, anti-TNB stigma is a risk factor for adverse alcohol
outcomes, often co-occurring with depression and anxiety. Stigma’s impact on alcohol use and mental health is
of particular concern in TNB young adults (YA; 21-30 years old), who report more adverse alcohol and mental
health outcomes than older TNB adults. For these YA, favorable romantic relationship experiences may
attenuate the mental health impact of anti-TNB stigma, yet stigma may contribute to adverse relationship
experiences (e.g., intimate partner violence; IPV) linked to adverse alcohol and mental health outcomes.
Accordingly, relationship-focused interventions have the potential to improve alcohol and mental health
outcomes in TNB YA. However, targets for such interventions remain unclear—first, because the mechanisms
by which stigma affects relationship experiences have not been identified, and second, because it is not clear
what kinds of general or TNB-specific relationship experiences should be addressed. This project responds to
these gaps, culminating in development of a relationship-focused intervention for alcohol use and co-occurring
depression/anxiety in TNB YA. In Aim 1, I will collect survey data from 200 TNB YA in romantic relationships to
revise and validate a new measure of TNB-specific relationship experiences. In Aim 2, I will use the new
measure in a 2-month weekly diary study of stigma, relationship experiences, alcohol use, and
depression/anxiety (n=250 TNB YA in romantic relationships). I will use these data to (1) assess weekly
associations of stigma and relationship experiences with alcohol use and depression/anxiety, and (2) identify
mechanisms by which stigma may affect relationship experiences. In Aim 3, I will adapt an existing type of
online alcohol intervention—technology-adapted motivational interviewing with personalized feedback—by
tailoring content for TNB YA and (if supported by Aim 2 findings) adding components to address relationship
experiences in the context of anti-TNB stigma. The intervention, Whole Selves, will be developed through a
multi-phase co-design process with 8 TNB YA, followed by evaluation of acceptability, usability, and
engagement in user-testing interviews (n=5 TNB YA in romantic relationships) and a single-arm feasibility
study (n=107 TNB YA in romantic relationships). In the K99 phase, this work will be coordinated with training in
psychometrics/scale development, diary methods, and community-engaged intervention development, with
mentorship from senior scholars known for applying these methods to research on stigma, alcohol use, mental
health, and romantic relationships. This training and mentorship will prepare me to develop and evaluate
Whole Selves in the R00 phase, producing preliminary data for an R01 efficacy trial proposal. Thus, the project
and associated training will allow me to launch an independent research career with the goals of (1) identifying
the mechanisms by which stigma affects young people’s alcohol use and mental health, and (2) partnering with
affected communities to mitigate these effects through scalable interventions.

Public health relevance
PROJECT NARRATIVE Excessive alcohol use contributes to a wide range of negative health outcomes, including accidents, violence, alcohol dependence, and cardiovascular disease. Existing interventions to reduce alcohol use may not be appropriate for TNB people, both due to inapplicable and potentially unacceptable content (e.g., gender- specific drinking guidelines) and because they do not address anti-TNB stigma as a key determinant of alcohol use in this population. Relationship-focused interventions have the potential to jointly address alcohol use and co-occurring depression/anxiety symptoms in TNB people by reducing adverse relationship experiences (e.g., intimate partner violence) that result from stigma—and leveraging supportive romantic relationships as a buffer against the effects of stigma.